Roybal Resource and Coordinating Center to Accelerate Translational Aging Research

PROJECT SUMMARY
The overall goal of this Roybal Coordinating Center to Accelerate Translational Aging Research (RCATAR)
is to provide strategic leadership, efficient coordination, inspired support, and creative dissemination of the
scientific advances for the Roybal Centers. We will support Roybal Consortium scientists as they conduct
translational research in the behavioral and social sciences of aging. Consortium scientists will use the NIH
Stage Model of behavioral intervention development as their guide for selecting the next appropriate pilot
intervention development activity. Their ultimate goal is to launch independent programs of research across a
myriad of aging and dementia caregiver topics. We will provide national leadership for the coordinated efforts of
the Roybal confederation by: 1) supporting their needs; 2) creating mechanisms for their active involvement; 3)
making visible their scientific advances; and 4) fostering collaboration and innovation. In our approach, we will be
informed by one overarching principle that will guide the design of all of our proposed activities: Scientists need
time to think, write, and experiment. For any creative, substantive contribution to aging science, scientist’s time is
a key, frequently unarticulated active ingredient. Increasing the time scientists have to focus on their science will
serve as our principle on which to plan the support, facilitation, and coordination provided to the Roybal centers
and their scientists.
The RCATAR will serve as the central resource for the annual Roybal meetings, monthly phone calls, and other
activities as needed by the Roybal Center Confederation. It will do so by working closely with the NIA Program
Officer and the other key stakeholders. Specifically, we will leverage team science and online community
approaches to coordinate, communicate, and facilitate thought-provoking activities for Roybal awardees. We
will use cutting-edge information science principles to establish, curate, and maintain a Roybal centralized
registry to track Roybal Pilot recruitment, retention, progress, and publications. We will draw upon our joint
expertise to provide systematic literature search, writing, and copy-editing support to the Roybal scientists. As
the RCATAR, we will provide multi-Roybal pilot funding, accelerate the sharing of best practices, and design
linkage activities to forge innovative partnerships. To proactively establish visible scientific advances we will
design a public website to host webinars, pilot results, publications, achievements, and relevant links. We will
serve as point contacts for the scientific and public communities about the impact of Roybal Centers. We will
design and monitor an evaluation system to determine the impact of the Roybal Centers. Finally, to foster
collaboration we will support the creation of joint manuscripts, presentations, workshops, and videos, and
seek opportunities for special issues and other prestigious outlets for Roybal scientists. Our RCATAR has the
experience and expertise needed to support the Roybal centers as they fulfill their promise to develop
behavioral interventions with wide impact on the lives of older adults and those who care for them.

Public health relevance
PROJECT NARRATIVE This Roybal Coordinating Center to Accelerate Translational Aging Research (RCATAR) intends to provide strategic leadership, efficient coordination, inspired support, and creative dissemination for the Edward R. Roybal Centers. All of our activities will be focused on supporting and optimizing scientists’ thinking and writing time.